Mechanism of Cranial Neural Crest Cell Migration

4123
PROJECT SUMMARY:
567 The cranial neural crest cells are natural stem cells that are born at the border between the neural
(future brain) and non-neural ectoderm (future skin) that exist in every vertebrate. Once established
these cells, move toward the front of the embryo to make all of the facial structures, including bones,
1089 cartilages, muscle and ganglia. When this process goes wrong (one third of all birth defects) it creates
very serious craniofacial defects. In addition, the method by which the cells move within the embryo
and invade other tissues and organs is similar to the process of cancer metastasis. Thus
1121 understanding how these cells move in the embryo is critical. We study the migration of these cells in
the vertebrate embryo of the frog Xenopus Laevis, a well established model that allows detailed study
1143 that are not possible in mammalian embryos. Specifically, thousands of embryos can be generated
for each experiment, they develop in a dish so that the mother does not need to be sacrificed, and all
1156 stages of development are easy to observe. The genome is known and most genes are well
conserved with their human counterpart. The goal of this proposal is to understand how, one protein
1178 at the surface of the cell, the protease ADAM13, can modify the function of a transcription factor
Arid3a to produce more of another transcription factor Tfap2α. ADAM13 is a metalloprotease that
1290 cuts other proteins at the surface of cells, while transcription factors bind to DNA in the nucleus to
either express or suppress genes. We are particularly interested in these two transcription factors as
2212 Arid3a has been shown to control the first cell decision in mammalian embryos to produce the
embryo proper or the placenta. Thus understanding how it is regulated is critical. The second
2234 transcription factor Tfap2α, is one of the most conserved during evolution. In Human, mutations of the
Tfap2α gene have been shown to cause Branchio-Oculo-Facial syndrome (BOF). This syndrome is
2256 manifested in newborn as defects in structures of the face, growth delay, skin wound, malformed ears
and deafness. We propose to study how ADAM13 controls Arid3a function and Tfap2α expression in
the Cranial Neural Crest cells, and to identify Human ADAM protein that can perform the same
function.

Public health relevance
PROJECT NARRATIVE: The goal of the project is to understand how ADAM13, at the surface of the Cranial Neural Crest cells, controls the activity of Arid3a, in the nucleus, to induce the expression of Tfap2α. Both Arid3a and Tfap2α have been shown to be critical for normal Development of mammalian embryos and in particular, in human TFAP2α mutation cause the Branchio-Oculo-Facial syndrome.